Applying Causal Inference and Deep Learning to Improve the Accuracy and Equity of Pulmonary Function Test Interpretation.

Project Summary
Race correction plays a central role in pulmonary function test interpretation, resulting in a decrease in
the rates at which respiratory impairments are identified in Black patients along with a decrease in the
severity of the impairments thus identified. In this way, race correction may promote health disparities
by obscuring respiratory impairments which would otherwise have been identified. However, while the
effect of race correction on pulmonary function test interpretation is apparent, the downstream clinical
consequences of race correction are unknown. No study has assessed the effect of race correction
on the clinical management of patients with respiratory disease. At the same time, few resources have
been developed to support the race-free interpretation of pulmonary function tests. Deep learning has
the potential to meet this need, offering a way to represent pulmonary function on the basis of flow-
volume loop morphology without reference to patient race, thus improving both the accuracy and the
equity of pulmonary function test interpretation. The aims of this study are to identify the effect of pul-
monary function test interpretation on the clinical management of patients with suspected respiratory
disease and to use deep learning to develop novel methods for representing pulmonary function in a
race-free manner. First, using more than 100,000 pulmonary function tests performed in the Univer-
sity of Pennsylvania Health System (UPHS), a regression discontinuity design will be used to estimate
the effect of pulmonary function test interpretation on the diagnosis, testing, and treatment of respira-
tory disease. This effect estimate will be combined with preliminary work demonstrating the effect race
correction has on pulmonary function test interpretation, to arrive at an estimate of the clinical conse-
quences of race correction. Second, unsupervised deep learning will be applied to flow-volume loops
collected from UPHS and from the National Health and Nutrition Examination Survey (NHANES) and
the construct validity of the resultant interpretations will be assessed. This project is supported by the
Palliative and Advanced Illness Research (PAIR) Center of the University of Pennsylvania, which has
an outstanding track record of advancing the careers of early stage investigators in health services re-
search. The candidate will be mentored by a team with expertise in causal inference, machine learning,
and health disparities. Experiential training through this project will be supplemented with coursework in
causal inference and deep learning. Findings from this work will directly inform the development of an
application for a K23 Mentored Career Development Award, which will use mixed-methods to investigate
the ways patients and physicians make use of pulmonary function test interpretations, identify actionable
clinical phenotypes within pulmonary function test data, and use supervised deep learning to support
the identification of these phenotypes when interpreting pulmonary function tests.

Public health relevance
Project Narrative Race correction plays a central role in pulmonary function test interpretation, decreasing the rate at which pulmonary defects are identified among Black patients. However, no studies have attempted to measure the downstream clinical consequences of race correction and few approaches have been developed to support clinicians in the interpretation of pulmonary function tests in a race-free manner. The proposed research uses a regression discontinuity design to measure the effect of race correction on the testing, diagnosis, and treatment of respiratory disease, while using deep learning to develop and validate a race-free approach to pulmonary function test interpretation on the basis of flow-volume loop morphology.